Investigating the nuclear organization of the inactive X in female lymphocytes

Project Summary
Chromatin organization in the nucleus is highly regulated to provide precise control over gene expression. The
most dramatic example of the relationship between chromatin structure and gene regulation is X Chromosome
Inactivation (XCI). XCI epigenetically converts one female X chromosome into a transcriptionally silent inactive
X (Xi) to equalize dosage between males and females. XCI is initiated by spreading of the long non-coding RNA
Xist in cis which re-organizes the Xi into a compact, bipartite structure, and targets the Xi to the nuclear periphery.
Maintenance of the Xi must be achieved to prevent aberrant expression of X-linked genes, which is associated
with autoimmune diseases and cancers. However, how silencing or nuclear organization of the Xi is regulated
during maintenance of XCI remains to be well understood. The current paradigm of maintenance is stable
association of Xist RNA with the Xi in all female somatic cells. Recently, the Anguera lab found a novel
mechanism of XCI in female lymphocytes. In naïve female B cells, Xist RNA is not localized to the Xi, but
surprisingly, after stimulation Xist RNA robustly returns to the Xi. One factor necessary for the localization of Xist
RNA to the Xi after B cell stimulation is the transcription factor Yy1, as loss of Yy1 abrogates the localization of
Xist RNA to the Xi in stimulated B cells. Yy1 was found to interact with multiple structural proteins in stimulated
female B cells, but whether these factors cooperate to regulate XCI is unclear. Additionally, how the dynamic
movement of Xist RNA affects the nuclear organization of the Xi is unknown. Using female follicular B cells, we
will interrogate the nuclear organization of the Xi, and determine how Yy1-interacting structural proteins
contribute to dynamic XCI maintenance. In Aim 1 we will perform allele-specific imaging of the Xi in naïve and
stimulated B cells to determine how dynamic movement of Xist RNA impacts organization of the Xi territory. We
will examine compaction of the Xi, localization of the Xi territory within the nucleus, and organization of the Xi
bipartite structure. We have recently found novel X-linked gene transcription from the Xi in female B cells, and
will use this to generate gene-specific probes to examine spatial localization of these genomic loci within the Xi
territory. We hypothesize that the dynamic movement of Xist RNA upon B cell stimulation will change the
organization of the Xi territory. In Aim 2, we will determine the role of three Yy1-interacting structural proteins,
LaminB1, Satb1, and condensins in XCI. Use of floxed mice to perform individual ex vivo deletions of each gene
will determine their requirement for Xist RNA localization to the Xi, enrichment of canonical Xi heterochromatin
marks H3K27me3 and H2AK119Ub, X-linked gene expression, and nuclear organization of the Xi territory. We
hypothesize that these proteins cooperate with Yy1 to maintain XCI through regulation of Xist RNA localization
and Xi nuclear organization in stimulated female follicular B cells. Together, these aims will expand our
knowledge of the mechanisms regulating XCI maintenance, and contribute to our understanding of nuclear
organization and gene regulation.

Public health relevance
Project Narrative X-Chromosome Inactivation (XCI) equalizes X-linked gene expression between females and males, and results in a structurally and epigenetically distinct inactive X (Xi). Aberrant expression of X-linked genes is associated with female-biased diseases, such as autoimmune disorders, but the mechanisms that regulate maintenance of XCI are still largely unknown. Immune cells have recently been shown to have novel maintenance of XCI, it is therefore critical to unravel how maintenance of Xi structure and silencing is regulated in immune cells to understand the connection between XCI and disease associated X-linked gene expression.